Reaching New Heights: Strengthening Health Professions Research at a Majority Hispanic-Serving Institution

Project Summary
Although health professions (allied health, nursing, social work, clinical psychology) represent more than 80%
of the healthcare workforce, rigorous research within these fields, a cornerstone of evidence-based practice, is
often trailing behind that of other medical professions. The urgency of closing this gap is amplified for health
professionals practicing in communities characterized by poverty, low educational attainment, health care
access challenges and, consequently, poor health outcomes. Thus, building and strengthening HP biomedical
research capacity is vital to improving health and addressing health disparities.
The primary goal of the proposed study is to lay the foundation for a robust health professions research
environment at the University of Texas Rio Grande Valley (UTRGV), one of the largest Hispanic-Serving
Institutions in the nation. Located along the Texas-Mexico border, UTRGV serves one of the most economically
disadvantaged and medically underserved regions in the United States.
Guided by a conceptual framework that integrates multiple levels and domains of influence, our overall
objective is to engage the UTRGV HP community in a structured, comprehensive research needs assessment
and develop a corresponding action plan characterized by clear, feasible, measurable, sustainable, and
institutionally championed action items that support high-quality, cutting-edge biomedical research.
To achieve our objective, our multidisciplinary team will conduct an environmental scan, analyze research-
related policies and procedures, assess faculty research capacity and needs, examine the institutional
research support infrastructure, and explore student research support and opportunities. This will allow us to:
Aim 1. Identify the structural, systemic, social, and psychological factors impacting biomedical research
productivity of HP faculty.
Aim 2. Identify the critical interactions between factors, domains and levels of influence enabling and hindering
research productivity.
Aim 3. Develop an action plan to strengthen biomedical research capacity of HP faculty, with a focus on health
disparities research in the context of Hispanic/Latino culture.
Our work will add a much-needed perspective, without which the potential of health research to better
understand, deal more effectively with, and eliminate health disparities in underserved populations will not be
realized. The proposed assessment and action plan promise to build a multidisciplinary, interprofessional
biomedical research capacity that will uniquely position UTRGV to advance health research, support the
pipeline of the future biomedical research workforce, and serve as a research capacity building model for
minority-serving, resource-limited institutions.

Public health relevance
Project Narrative Health research is vital to improving community health and is most effective when conducted synergistically between medical and health professionals (allied health, nursing, social work, clinical psychology) who represent more than 80% of the healthcare workforce. Closing the significant gap in the level of research skills and engagement between medical and health professions is critical to accelerating progress in addressing the most complex challenges on the public health agenda. The successful implementation of the proposed research needs assessment and corresponding action plan will result in an effective model that will support a robust multidisciplinary, interprofessional research capacity to advance health and health disparities research at minority-serving, resource-limited institutions.